The Impact of p53 Variants on Liver Disease

Research Project 3 – Abstract
The TP53 tumor suppressor is arguably one of the most important genes in cancer, given that it is inactivated by
somatic mutations in about 50% of human tumors. p53 serves to protect cells in response to numerous biological
and environmental stresses, such as DNA damage, reactive oxygen species (ROS), and oncogene activation.
Upon insult, p53 responds rapidly by activating a plethora of cellular responses that inhibit the growth of damaged
cells, including cell cycle arrest, senescence, and apoptosis. In addition to mutations, single nucleotide
polymorphisms (SNPs) in the TP53 gene can also have a significant impact on p53 function. We have shown
that a coding region polymorphism at amino acid 47 of p53 (Pro47Ser, hereafter S47), causes this protein to
have markedly impaired tumor suppressor function. The S47 polymorphism of p53 (rs1800371) is found in
approximately 2% of African Americans. Genetically engineered p53 “S47 mice” are prone to spontaneous
tumors. Over 30% of these mice developed hepatocellular carcinoma (HCC), the most common type of liver
cancer. We found that S47 cells and mice were defective for their ability to induce ferroptosis, an iron and lipid-
mediated form of cell death. This ferroptotic defect leads to an increase in iron accumulation in cells and tissues.
Consistent with these findings, we recently reported that the S47 variant of p53 is significantly associated with
iron overload in African Americans, a disorder that causes iron accumulation and an increased predisposition to
liver fibrosis and cancer. Collectively, our data suggest that the S47 variant of p53 may be a significant risk factor
for liver disease in African Americans. The broad, long-term objective of this proposal is to test the hypothesis
that the S47 variant is impaired for p53-mediated tumor suppression in the liver and has a reduced ability to
suppress HCC. In Aim 1, we will use genetically engineered mouse models and cell lines to determine the impact
of the S47 variant of p53 on the initiation and progression of HCC. In Aim 2, we will use our human WT and S47
CRISPR knock-in liver cancer cell lines, and the S47 mouse, to identify personalized therapeutic approaches for
S47 individuals with HCC. To achieve these goals, we have put in place a strong and collaborative Mentoring
Team: (1) Dr. Don Rockey, MD; (2) Dr. Paul Monga, MD; and (3) Dr. Antonis Kourtidis, PhD. Each laboratory
has unique and complementary expertise in fibrosis/cirrhosis, mouse models of HCC, and targeted therapy. We
expect to reveal the underlying mechanisms by which the S47 variant of p53 leads to increased liver disease
risk. We also expect to uncover more efficacious therapies for HCC in this population.